LEARRN: Didactic Interactions Component

PROJECT SUMMARY
The LeaRRN Techniques Component will modify LHS research techniques and resources so that they are
focused on the needs of rehabilitation researchers and aligned with the priorities of our LHS Innovation Hub
partners. Our first step is to identify existing gaps in LHS research knowledge across the broad rehabilitation
research communities and match those needs to the priorities identified by our LHS Innovation Hub partners.
This work will guide development of resources and adaptation of techniques to improve rehabilitation research
in real-world settings and develop a critical mass of rehabilitation researchers focused on LHS research. The
overarching purpose of the LeaRRN Techniques Development Component is to modify available LHS research
techniques and resources to enhance achievement of LHS research competencies in the rehabilitation
research community. This is urgently needed because rehabilitation researchers have had little exposure to
many LHS research core competencies in their academic training. LHS research draws on theoretical and
applied methods from a variety of fields. While rehabilitation research training may address some LHS
research competencies, such as asking meaningful questions, applying appropriate methods, and ethics of
research; rehabilitation research training does not address key competency areas required for engaging and
conducting research within LHS. For example, most rehabilitation researchers have little to no exposure to key
competency domains such as system science, improvement and implementation science and stakeholder
engagement. Most rehabilitation researchers are unprepared to conduct research within a real-world health
system. The Techniques Development component has the following specific aims: 1) assess gaps in LHS
research competencies and resource needs of the broad rehabilitation research community; 2) develop and
modify LHS research resources and techniques to address the needs of the rehabilitation research community
and priorities of the LHS Innovation Hub stakeholders. While we know from experience and anecdote that LHS
competencies are lacking across rehabilitation disciplines, we do not know the extent of these gaps or how
they differ across disciplines. We will engage a multidisciplinary expert panel to inform development of a
survey to assess key competencies within the seven LHS research domains. The survey, distributed across
rehabilitation research disciplines, will assess knowledge gaps and priority areas to target with didactic training.
The survey will be re-administered in Years 3 and 5 to assess LeaRRN’s impact and guide future activities.
Needs identified in Aim 1 will be prioritized by LHS Innovation Hub partners, and the results will be used to
guide development of Use Case Examples and other resources that will be linked to the resources and
activities of the Didactic component for dissemination. The work of the Techniques Development component
will bridge the gap between content knowledge and application by identifying and prioritizing the needs of the
rehabilitation research community and developing techniques and resources to address these needs.